AKT/mTOR signaling and regulation of cell cycle in B-cells

Project Summary/Abstract
The capacity of β-cells to expand in response to insulin resistance is critical to develop type-2 diabetes and β-
cell proliferation is a major component for these adaptive responses. The long-term goal of our previous and
proposed studies under this award is to understand the molecular mechanisms that regulate β-cell mass and
function. During the current funding period, we identified mTOR/raptor complex (mTORC1) as a major player in
regulating β-cell mass and insulin secretion. We uncovered the individual contribution of the mTORC1
downstream targets 4E-BP, S6 kinases (S6K) and ULK on the regulation of -cell growth, proliferation,
survival, insulin processing and secretion. We also discovered a novel mTORC1/4E-BP2/eIF4E/SH2B1
positive feedback loop that increases IRS2 signaling. However, uncertainty remains as to how mTORC1 acting
on 4E-BP2, S6K and ULK controls -cell mass and insulin secretion. The objective of this application is to build
on these observations and determine how mTORC1 regulates -cell mass and insulin secretion. We
hypothesize that mTORC1 regulates (i) β-cell mass in a 4E-BP2/SH2B1 and JNK3-dependent manner and (ii)
insulin secretion by regulating stages proximal to calcium influx and autophagy mediated process. The specific
aims are (1) Establish how 4E-BP2/eIF4E acting on SH2B1 and JNK3 regulates β-cell mass expansion. (2)
Determine how mTORC1 modulates insulin secretion and adaptation to diabetogenic conditions. This proposal
will provide important insights into the molecular mechanisms that govern β-cell mass and insulin secretion by
mTORC1. This information can be used to expand drug development opportunities for diabetes.

Public health relevance
Project Narrative Failure of β-cells to expand or adapt to insulin resistance results in type 2 diabetes. The current evidence support the concept that mTORC1 is active in states of increased insulin demand and plays a major role in β- cell adaptation to insulin resistance. The goal of this application is to unravel how mTORC1 regulates β-cell mass and insulin secretion in an effort to develop strategies to identify pharmacological targets to improve β- cell mass and function for the treatment of diabetes.